COMPLIANCE IN THE PHYSICIANS'HEALTH STUDY

The Physicians' Health Study is a randomized, double-blind placebo-controlled primary prevention trial designed to test whether 325 mg aspirin every other day reduces risks of cardiovascular disease and whether 50 mg beta-carotene on alternate days decreases cancer incidence among 22,071 male U.S. physicians, aged 40-84 years in 1982. Compliance with study pills, the use of non-study aspirin and platelet active drugs, specific side effects of aspirin, the incidence of conditions indicating aspirin use, and study outcomes were assessed at 6 monthly intervals during the first year and annually thereafter. The blinded aspirin component of the trial was terminated early and participants were unblinded on January 25, 1988, due to the emergence of a statistically extreme benefit of aspirin on both fatal and nonfatal myocardial infarction, as well as the extraordinarily low cardiovascular mortality rates among study participants. We propose to evaluate the relationships of compliance in taking aspirin or aspirin placebo with the risk of major cardiovascular endpoints. Separate dose-response relationships will be estimated in the aspirin and in the placebo group to determine whether compliance in the placebo group is associated with lower risk, as has been found in some previous trials. Rates of cardiovascular endpoints in the placebo group relative to the aspirin group will be adjusted for time-varying compliance with study tablets, and the use of non-study aspirin and platelet active drugs. In addition, baseline characteristics of the population and longitudinal assessment of side-effects and new conditions suggesting aspirin therapy will be used as predictors of compliance in taking study pills separately in the aspirin and placebo groups. Similar longitudinal analyses will determine predictors of the use of non-study aspirin and platelet active drugs. The proposed analyses are intended to supplement the already published intent-to-treat analyses. They will provide observational evidence concerning dose of aspirin and the risks of major cardiovascular endpoints. Examining modification of the aspirin effect in reducing risk of myocardial infarction according to level of compliance will aid in the generalizability of results to less motivated populations. Evaluating determinants of good study compliance will be of benefit to future large scale clinical trials.